Cell Interactions Controlling Neural Differentiation

DESCRIPTION (provided by applicant): The Notch signaling pathway defines a cell interaction mechanism, which defines one of the cornerstones of the signaling backbone in metazoans. The essential role Notch signals play in the early development of the nervous system, has been recognized fifty years ago and it has become clear that Notch signals are essential in almost all aspects of neural development starting from the differentiation of neural stem cells to the elaboration of neuritis in postmitotic neurons. Numerous analyses in vertebrate and invertebrate model systems as well as in humans over the years has, however, established that the action of the Notch pathway is far broader than the confines of the nervous system and that it is used throughout development to couple the fate choice of a particular cell to the fate of the next door neighbor ultimately affecting proliferation, apoptotic and differentiation events. The overall goal of this proposal is to dissect the molecular elements of Notch signaling and gain insight into the complexity and the degree to which Notch signaling response is tissue specific. We will use both classic as well as genomic approaches to achieve our goals. Four specific aims are proposed a) In an attempt to gain insight into the function and biology of mastermind, a nuclear effector of Notch signals, we propose to carry out a classic genetic screen for second site modifiers of mastermind phenotypes as well as examine some of the biochemical properties of Mastermind. b) We propose a two-hybrid approach in an attempt to construct a protein interaction map involving most of the known elements of the Notch pathway c) We will examine the transcriptional complexity of the Notch signal response, in order to study the tissue specificity, signal integration with other pathways and quantitative aspects of Notch signals, d) Finally we propose molecular genome-wide screens for modifiers of Notch activity using an RNAi approach in tissue culture cells. These studies will be complemented by chemical screens for Notch signal modifiers.